Functional Neuroimaging in Childhood Absence Epilepsy

[unreadable] DESCRIPTION (provided by applicant): Patients with childhood absence epilepsy (CAE) have repeated 5-10 s episodes of unresponsiveness, associated with a "spike-wave" discharge (SWD) on electroencephalography (EEC). In addition to the deficit during seizures, many children also suffer from milder attention impairment between absence attacks. CAE affects 10-15% of children with epilepsy. The fundamental mechanisms of altered brain function and impaired attention in CAE are not known. Although considered a form of generalized epilepsy, both human and animal data suggest that SWD involve selective cortical and subcortical networks, while sparing other regions. Our central hypothesis is that SWD cause dysfunction in specific networks important for attention, including the medial frontal cortex and thalamus. Impairment of these attention networks may cause deficits both during and between seizures. If confirmed, this may lead to regional therapies targeted at improving impaired attention in patients with CAE. Functional magnetic resonance imaging (fMRI) provides a window to brain function, but is indirectly related to neuronal activity. We will, therefore, map abnormal function in CAE, both at baseline and during seizures, using simultaneous EEG-fMRI and arterial spin labeled cerebral blood flow (CBF) measurements, to more closely estimate neuronal activity changes. This will enable us to determine if attention networks are impaired in CAE, both during seizures and at baseline. We will then test attentional vigilance between and during seizures in CAE using a continuous performance task (CRT). At the same time, we will use functional neuroimaging to determine whether impaired attention between and during seizures is related to abnormal function in specific brain regions. RELEVANCE: Impaired attention during and between absence seizures has a major negative impact on patient quality of life due to deficits in school performance, potential for injuries, and social stigma. By understanding the fundamental mechanisms, and brain regions crucial for impaired attention in this patient population, new treatments including designer drugs and other targeted therapies may be developed with the goal of blocking seizures and preserving attention. Understanding mechanisms of impaired attention in this form of epilepsy may have implications for treating other types of epilepsy as well. [unreadable] [unreadable] [unreadable]